Generation & Regulation of Tfh13 cells that drive Pathogenic IgE in Allergy

Abstract:
Allergies to food and environmental antigens have steeply grown to epidemic proportions. One
key determinant of IgE-mediated clinical symptoms is the high-affinity of the IgE antibody for a
given allergen which we will refer to as “pathogenic IgE”. A life-threatening complication
associated with pathogenic IgE mediated allergic reaction is anaphylaxis, which can lead to the
death of otherwise healthy individuals, including children. Follicular helper T cells (Tfh), but not
Th2 effector cells, are primarily responsible for directing the affinity, longevity and isotype of
antibody produced by B cells, including IgE. The nature of the Tfh cells that drive high-affinity,
pathogenic IgE to allergens was unclear. We recently discovered that allergens drive the
differentiation of a novel Tfh cell subset namely Tfh13 cells in addition to canonical Tfh2 cells.
Tfh13 cells co-produce IL-4 and IL-13, express low levels of IL-21 and are absolutely required for
allergen-specific pathogenic IgE production. Importantly, Tfh13 cells are found in patients with
food or respiratory allergies but not in healthy individuals. Despite the importance of Tfh13 cells
in allergies, currently little is known about how Tfh13 cells differentiate during allergic sensitization.
While Tfh2 cells are elicited in response to vaccinations, viral infections, and almost all type 2
responses, Tfh13 cells are specifically generated in allergic disease states. This highlights the
existence of vital signals during sensitization that foster Tfh13 cell differentiation, with the
possibility of conflicting signals in non-allergic contexts. The goal of our proposal is to fill these
gaps in knowledge and thereby elucidate pathways that lead to Tfh13 cell differentiation. The
overarching hypothesis that our proposal aims to test is that Tfh2 cells and Tfh13 cells have
distinct immunological requirements for their differentiation. We have developed tools including
cell specific knockout mice to 1) determine the role of non-conventional antigen presenting cells
in promoting Tfh13 cell differentiation to allergens and 2) elucidate the how the balance of type II
cytokines and their inhibitory signals determine the Tfh2 versus Tfh13 cell fate decision. The broad
impact of our studies could be substantial, enabling the elucidation of the cell extrinsic and intrinsic
pathways of Tfh13 cell differentiation that could be leveraged to curtail allergic disease.

Public health relevance
Project Narrative Despite being one of the least abundant antibody isotypes, IgE can have devastating consequences when it triggers anaphylaxis, which is a life-threatening allergic reaction. A subset of T follicular helper (Tfh) cells, namely IL-13-producing Tfh13 cells, are critical for the induction of anaphylactic IgE to allergens. By elucidating the mechanisms of Tfh13 cell induction and differentiation during allergic sensitization, this project will valuable insights on the biology of Tfh cells and identify potential cellular and molecular targets to control anaphylactic IgE to allergens.